Establishing Oprm1 exon 7-associated variants as novel therapeutic targets for mitigating adverse effects of clinically used mu opioids without altering analgesia in pain management

Project Summary/Abstract
Mu opioids, such as fentanyl and oxycodone, remain in the mainstream for moderate-to-severe pain
management. However, they also produce many side-effects, leading to the development of opioid use disorder,
a main cause of the opioid epidemic and climbing opioid overdose death. The actions of mu opioids are primarily
mediated through the mu opioid receptors encoded by the single-copy mu opioid receptor gene, OPRM1, that
undergoes extensive alternative splicing, creating multiple splice variants. One set of OPRM1 variants, exon 7-
associated full-length 7TM C-terminal variants (E7 variants), contain a unique intracellular C-terminal tail
sequence with 30 amino acids encoded by E7 that are abundant and highly conserved from rodents to humans.
Culminative evidence has indicated that E7 variants contribute to several mu opioid-induced adverse side-effects.
First, truncating E7-enocded C-terminal tails in mice (mE7M-B6) attenuated mu opioid-induced tolerance, reward,
and respiratory depression without effect on analgesia. Second, similarities and dissimilarities in several
phenotypes between mE7M-B6 and β-arrestin2-KO mice suggest that E7 variants involve β-arrestin2-dependent
and β-arrestin2-independent mechanisms. Third, a mouse model in which only a single E7 variant, mMOR-1O,
is expressed (mMOR-1O-KI) showed enhanced morphine tolerance and reward, complementing those from
mE7M-B6 mice. Finally, a vivo-morpholino antisense oligonucleotide (ASO) and a newly developed rabbit
monoclonal antibody (RabmAb) targeting E7 variants diminished morphine tolerance and reward in mice.
Together, these observations strongly support our central hypothesis that Oprm1 E7 variants mediate several
adverse effects associated with clinically used mu opioids, such as tolerance, reward, and respiratory depression,
and targeting E7 variants can diminish these adverse effects but maintain mu opioid analgesic potency via other
Oprm1 7TM variants. These observations also provide compelling rationales for further investigating the role of
Oprm1 E7 variants in various actions of mu opioids using ASOs and antibodies as proposed in this application
with four independent, but integrated specific aims. Aim 1 is to characterize ASOs and RabmAbs that target
mouse Oprm1 E7 variants in both in vitro cell models and in vivo C57BL/6J (B6) mice, providing the necessary
information for designing experiments in Aims 2 & 3. Aims 2 & 3 are to investigate the effects of the selected
ASO and RabmAb on mu opioid-induced tolerance, reward, addiction, and respiratory depression in B6 mice
under naive (Aim 2) and chronic pain conditions (Aim 3), respectively. Aim 4 is to develop and characterize a
nanobody or an ASO targeting human/monkey exon O (E7 homolog) sequences and investigate the effects of
the nanobody or ASO on mu opioid abuse potential in rhesus monkeys. The proposed studies promise to yield
significant findings in establishing the E7 variants as therapeutic targets and provide the groundwork for
developing a therapeutic medication that combines clinically used mu opioids with an inhibitor (nanobody or ASO)
to mitigate the adverse effects of mu opioids in pain management.

Public health relevance
Project Narrative Mu opioids such fentanyl and oxycodone are potent in relieving pain, but produce adverse side-effects such as tolerance, respiratory depression, reward and addiction, leading to the worldwide opioid epidemic and climbing opioid overdose death. The proposed studies aim to establish the mu opioid receptor exon 7-associated full- length variants as therapeutic targets using antisense oligonucleotide (ASO) and antibody, providing the groundwork for developing a therapeutic medication that combines clinically used mu opioids with an inhibitor (antibody or ASO) to mitigate the adverse effects of mu opioids in pain management.